Estrogens, Cardiometabolic Health, and Female Cognitive Aging

Overall Summary
Loss of ovarian function at menopause is hypothesized to be a risk factor for Alzheimer’s disease and related
dementias. Research in preclinical models indicates that estrogens are neuroprotective and can positively
impact the cognitive aging trajectory. However, clinical data have been equivocal as to the benefits of
menopausal estrogen therapy to the brain and cognition. Variation in response to estrogen therapy in women
suggests that pre-existing disease such as hypertension and metabolic syndrome can modulate mechanisms
of estrogen action. These alterations may consequently reduce or reverse protections estrogens provide
against cognitive decline, Alzheimer’s disease, and related dementias. The Program objective is to determine
the impact of cardiometabolic status on the ability of exogenously administered estrogens to benefit the brain
and cognition in an aging female rodent model. The overall hypothesis is that administration of estrogens in
aging females will benefit the brain and cognition if initiated in healthy subjects, but will provide no benefits if
initiated in the presence of cardiometabolic disease. Mechanisms by which these divergent effects occur are
hypothesized to involve both alterations in mechanisms by which estrogens act directly on brain memory
systems and mechanisms by which estrogens act on cardiometabolic systems, which in turn impact brain
memory systems. Experiments under the four Projects will test this hypothesis. Project 1 will test the
hypothesis that cardiometabolic disease, due to associated dysfunction of the ubiquitin/proteasome system,
will disrupt the ability of estrogens to regulate levels of ERα in the hippocampus, regulation that is necessary
for midlife estradiol treatment to exert lasting impacts on memory. Project 2 will test the hypothesis that the
presence of cardiometabolic disease impedes estrogen’s beneficial cognitive effects by blunting neurovascular
coupling via endothelial nitric oxide synthase uncoupling, thus impairing the local network activity and synaptic
plasticity required to preserve functional cortical circuits and therefore for cognition. Project 3 will test the
hypothesis that cardiovascular disease alters the estrogen receptor profile, altering downstream molecular
signaling pathways and attenuating its protective vascular effects and subsequent impact on cognition. Project
4 will test the hypothesis that insulin resistance caused by high fat diet impairs downstream signaling pathways
necessary for estradiol’s beneficial influence on central regulation of glucose homeostasis, hippocampal long-
term potentiation, and hippocampus-dependent cognitive function. The Administrative Core will provide
leadership to the Program and ensure integration of all Program components. The Cardiometabolic and
Hormones and Behavior Cores will provide critical consistencies in models and procedures to ensure scientific
rigor and reproducibility of results across projects. Results will identify conditions under which estrogen
treatment will (or will not) change the cognitive aging trajectory that could potentially reduce or delay age-
related cognitive disease including Alzheimer’s disease and vascular dementia.

Public health relevance
Overall Project Narrative The Program Project will determine if and how estrogens interact with cardiovascular and metabolic health to impact the brain and cognitive aging. Understanding conditions under which administration of estrogens are beneficial or harmful is critical to developing a personalized approach in recommendations for use of menopausal hormone therapy in women.